Addiction Connectome Core

PROJECT SUMMARY: Addiction Connectome Core
The pattern of connections between brain regions (the brain’s wiring diagram) determines how they communicate
and ultimately, how they contribute to behavior. Understanding how connectivity changes with drugs is essential
for determining the mechanisms of addiction. Recent innovations in neuroimaging have allowed scientists to
study neural connectivity across the whole brain. This work has taken place mostly in humans. At the same time,
invasive methods in animal models have led to a wealth of information on cellular changes. However, these two
approaches remain largely disconnected. The Addiction Connectome Core (ACC) will bridge this translational
gap by supporting the development of a whole-brain, multimodal connectome in rodents and non-human
primates. The connectome will shed light on the predictors and consequences of addiction. In addition to
developing novel imaging tools (e.g., dopaminergic imaging) and collecting core data for the connectome, we
will also facilitate the integration of complementary data from Center Users and researchers outside of University
of Minnesota. The ACC will integrate and make publicly available data bearing on its mission from three sources:
(1) data specifically collected for the Core, (2) data collected by the other Cores (Structural Circuits Core and
Addiction Neural Dynamics Core), and (3) data collected by extramural scientists. As such, the core will lead to
the generation and curation of a high-quality translational multi-modal connectome of structure and function as
it relates to addiction.